Development of a first-in-class antifungal agent to treat Candidiasis and Candidemia

SUMMARY
Multidrug resistant (MDR) yeasts of the genus Candida cause life-threatening nosocomial infections in the US
and globally and new antifungal drugs are urgently needed to combat this threat. We have identified a terpenoid
natural product (NP; M743) which inhibits an early step in glycosylphosphatidylinositol (GPI) anchoring of
mannoproteins to the fungal cell wall. Clinical development of fosmanogepix (FMGX), which inhibits another
enzyme in this same process, provides strong clinical validation for the GPI biosynthetic pathway as a novel
target for new antifungals. M743 displays potent in vitro antifungal activity across all clinically relevant Candida
spp. tested. M743 is shown to be chemically tractable and a semi-synthetic derivative (M720) demonstrates
efficacy in a murine model of disseminated Candidiasis and an acceptable preliminary cytotoxicity profile, with
its lethal dose (LD50) exceeding 300 mg/kg by IP administration in mice. We propose to develop a first-in-class
intravenous (IV)-administered antifungal agent to treat life-threatening Candidemia and Candidiasis infections
caused by MDR Candida albicans, C. auris, C. glabrata and lesser prevalent Candida species.
Specific Aims. Aim 1. NP Studies to Support M743 Development. M743 fermentation and isolation, whole
genome sequencing, scale up, identify and characterize congeners, and genetic engineering of the biosynthetic
gene cluster for strain improvements and downstream production of M743 and its de-acylated precursor.
Milestone 1. M743 production requirements involve i-ii) 1.5 g of M743 and genome sequence of producer, iii)
structure elucidation of congeners for SAR studies, and iv) strain improvements to provide de-acylated precursor
of M743 in large scale (>10 g/ batch). Aim 2. Lead Optimization and Preclinical Candidate (PCC) Selection.
Synthesize and characterize up to 200 new analogs emphasizing optimization in antifungal potency, target-
selectivity, frequency of resistance (FOR) reduced serum binding and cytotoxicity, parenteral PK, PKPD index,
and efficacy in a neutropenic murine Candidiasis infection models of C. albicans, C. auris, and C. glabrata.
Milestone 2. Identify 2 compounds demonstrating the following favorable attributes i) Mcd4-selective activity, ii)
MIC90 < 1 ug/mL vs Candida spp. iii) acceptable FOR (<1 x 109), iv) in vitro therapeutic index (TI) versus human
cell lines (TI>128-fold) and no red blood cell (RBC) lysis (RBC> 128 ug/mL), v) reduced ppb (< 95%) and no
PANLABS off-target activity (IC50>10 uM), vi) improved PK suitable for IP bid dosing, defined PKPD index, and
vii) successful dose ranging studies to guide dose selection. The top 2 analogs achieving dose dependent
efficacy in these infection models (defined as > 3 log reduction in fungal burden) and overall favorable drug-like
properties will be selected as a PCC and back-up. Aim 3. Safety, Metabolism, PK, and Toxicology. Safety
assessment of the PCC using non-GLP material to de-risk the program before GLP material is available to
conduct more extensive IND-enabling toxicology studies. Milestone 3: Demonstrate a safe in vivo therapeutic
index based on the determined NOAEL in Aim 3 and effective efficacy by IP dosing regimen identified in Aim 2.